Dissecting molecular mechanisms implicated in age- and osteoarthritis-related decline in anabolism in articular cartilage

ABSTRACT
The reparative capacity in human articular cartilage is generally considered to be low or negligible, and this
intrinsic capacity decreases with age. As a result, articular cartilage injuries often result in irreversible damage
leading to osteoarthritis (OA). We and others have recently defined heterogeneity in articular chondrocytes at
both the molecular and cellular levels. Work in mice and other mammals has implicated a subset of cells in the
superficial layer of articular cartilage as the source of regenerative capacity; to date, these findings have not
been extended to a specific population of chondrocytes in human ontogeny. Our previous studies have shown
that unlike adult chondrocytes, fetal chondrocytes are highly proliferative and migratory, and exhibit high basal
levels of phosphorylated signal transducer and activator of transcription 3 (pSTAT3). Our preliminary data also
nominate cells expressing integrin α4 (ITGA4) and bone morphogenetic protein receptor (BMPR1B) as the most
immature chondrocytes in human articular cartilage throughout human development. Moreover, we have shown
at the molecular level that ITGA4+BMPR1B+ cells are enriched for active STAT3 (pSTAT3), which are known to
drive proliferation, anabolism and preserve differentiation potential. Importantly, adult ITGA4+BMPR1B+ cells are
localized to the superficial layer and also express the highest levels of SOX9, which is strongly identified with
osteochondral progenitor identity and anabolism; indeed, ITGA4+BMPR1B+ cells are robustly chondro- and
osteogenic in vitro. The percentage of ITGA4+BMPR1B+ cells and levels of pSTAT3 tightly correlate with
biological age, decreasing from 20-30% in developing joints down to 1-2% in aged adult healthy cartilage. We
hypothesize that active STAT3 is expressed in immature articular chondrocytes and is a permissive factor
required for immature cell anabolism and differentiation in response to specific instructive signals in the niche.
We propose to define the direct transcriptional targets of STAT3 in human articular chondrocytes at different
ontogenic stages and under conditions similar to the pro-inflammatory state driven by IL-6 family cytokines in
OA. To address how IL-6 family cytokines can drive varied biological and functional outcomes in a context-
specific manner, we will employ nanoproteomics and targeted mutagenesis to determine how specific post-
translational modifications in the core IL-6 family cytokine receptor gp130 differ in fetal vs. adult chondrocytes
stimulated with IL-6 family cytokines. Finally, we will apply single cell RNA-Seq to further refine the molecular
and cellular phenotype of immature articular chondrocytes. In parallel, we will assess the molecular and
functional consequences of STAT3 gain and loss of function in articular chondrocytes. We propose that cells
with higher levels of pSTAT3 will evidence broader differentiation potential in vivo, resulting from changes
mediated by STAT3 in chromatin conformation. The overall impact of this highly innovative study is to define the
cellular and molecular phenotype of immature articular chondrocytes throughout human ontogeny and to link
this to the potential for cartilage repair and/or regeneration during aging.

Public health relevance
PUBLIC HEALTH RELEVANCE Osteoarthritis also known as a degenerative joint disease is characterized by the degradation of large synovial joints such as the knee or hip joint and this process involves both articular cartilage and subchondral bone. This disease is one of the major burdens of modern medicine negatively currently affecting life of 25 million Americans. The ultimate objective of the proposed project is to study molecular mechanism of chondrocyte senescence and activation via analysis and genetic modulation of the gp130-STAT3 axis; our laboratory has previously developed several small molecule regulators of this pathway. These data are essential for advancing new small molecule-based therapeutic approaches for articular cartilage restoration, which in turn will reduce the morbidity from acute cartilage injuries and degenerative joint disease.